BIMANUAL AND EYE-HAND COORDINATION IN PARIETAL CORTEX

ABSTRACT Primates, including humans, are expert at coordinating their two arms together with their gaze to facilitate skilled behavior. Our overall goal is to understand the neural correlates of “hand-eye-hand” coordination. We view bimanual and eye-hand coordination as flexible behavior that reflects task-specific interactions among neuronal circuits. A classical description of eye-hand coordination is that saccade and reach reaction times are correlated. Yet coordination is much more than just correlated start times, and coordination can take many forms. For example, we can use each of our hands to perform the same action at the same time, the same action at different times, or different actions at similar times. In seeking the neural correlates of coordination, particular circuits and structures in the brain appear to be associated with particular effectors and/or actions. We hypothesize that coordination involves specific modules exchanging information at specific times and, importantly, in a task-specific manner. This proposal will assess inter-areal and inter-hemispheric exchanges of information and gather evidence that they subserve a range of hand-eye-hand coordination challenges. We focus on motor planning in posterior parietal reach region (PRR) and the lateral intraparietal area (LIP), early modules in the visuomotor pathways for reaches and saccades, respectively. Animals will perform simple, natural unimanual and bimanual reaches and saccades while we measure cross-area LFP-LFP and spike-LFP coherence to identify task-speciﬁc patterns of information ﬂow. We also introduce a new method to determine the direction of information transfer, a critical factor in understanding the overall computational picture. By describing hand-eye-hand coordination as a set of behaviors that are flexibly recruited to meet specific task goals, and by characterizing the neural correlates of this recruitment as a shifting network of inter-areal connectivity, this work has the potential to change the way we think about motor coordination.

Public health relevance
PROJECT NARRATIVE The central goal of this proposal is to understand the neural systems subserving coordinated eye and arm movements. Coordinated movements are central to our daily functions, yet are often compromised by strokes, trauma and degenerative diseases. A better understanding of the brain systems underlying coordination may beneﬁt clinical diagnosis and prognosis in these conditions and eventually lead to improved treatment. This work will also provide information that will improve neural prosthesis design. In particular, our work will allow brain-machine interfaces to better distinguish commands intended for one versus the other limb, and enable a patient to move their artiﬁcial limb in ways that ﬁt better with their natural patterns of motor coordination.